Repetitive Stretch-Induced Myocardial Stiffening in Chronic Coronary Artery Disease

Abstract
Heart failure with preserved ejection fraction (HFpEF) has emerged as the most common form of heart failure
among Veterans, yet there is currently a paucity of treatment strategies that have been proven to improve
prognosis. A primary reason for the lack of effective therapies for this increasingly prevalent condition is the
limited understanding of mechanisms underlying myocardial stiffening, a key pathophysiologic component of
HFpEF that is directly linked to exertional dyspnea, the cardinal presenting symptom of the disorder. The
overarching goal of this proposal is to address this problem by elucidating the role of repetitive stretch-induced
remodeling of the cardiac extracellular matrix (ECM) as a mechanistic link between chronic coronary artery
disease (CAD) and HFpEF, two conditions that are extremely common in the Veteran population. Based on our
preliminary data from multiple clinically-relevant swine models of heart disease, we hypothesize that
myocardial stiffening develops in the setting of chronic CAD as a result of repetitive stretch-induced
fibrosis caused by intermittent elevations in left ventricular (LV) preload. If so, this may explain why such
a large proportion of the HFpEF population exhibits angiographically-significant epicardial CAD (~60-70% in
multiple cohorts) and might have important clinical implications related to the use of coronary revascularization
in these patients, since the reversibility of repetitive stretch-induced myocardial fibrosis is unclear.
To test this hypothesis, we will utilize a porcine model of chronic epicardial CAD to better understand how
exposure to episodic preload elevation influences remodeling of ischemic and non-ischemic regions of the left
ventricle in this setting. In Aim 1, implantable telemetry will be used for continuous hemodynamic monitoring to
quantify the frequency of preload elevation in swine with either multi-vessel (MV-CAD) or single-vessel CAD
(SV-CAD) and determine whether repetitive preload elevation is required for the development of interstitial
fibrosis in remote, non-ischemic myocardium. In Aim 2, percutaneous angioplasty will be performed in swine
with MV-CAD and swine with SV-CAD to determine if repetitive stretch-induced stiffening associated with MV-
CAD dictates whether LV fibrosis is reversed by revascularization. Post-mortem analysis of isolated cardiac
fibroblasts and decellularized cardiac ECM from these models will be completed in Aim 3 to assess the mechanistic
role of ECM-dependent fibroblast activation in repetitive stretch-induced LV stiffening and determine whether
increased ECM stiffness per se causes protracted fibroblast activation that promotes persistent fibrosis through a
self-sustaining positive feedback loop.
These aims will be addressed by a multi-disciplinary investigative team using an integrative research
approach that combines serial investigation of regional and global myocardial mechanics with ex vivo mechanical
and biological analysis of myocardial tissue strips, isolated cardiac fibroblasts, and decellularized cardiac ECM.
Collectively, these experiments in translationally-relevant swine models of heart disease are expected to
establish repetitive stretch-induced ECM remodeling as a mechanistic link between CAD and HFpEF and
facilitate the development of novel therapeutic strategies to reduce the unacceptably high morbidity and mortality
of Veterans with these increasingly prevalent conditions.

Public health relevance
Cardiovascular disease is the leading cause of death among Veterans and congestive heart failure, in particular, is among the most common conditions resulting in death, disability, and hospitalization. Heart failure with preserved ejection fraction (HFpEF) has emerged as the most common form of heart failure, but our poor understanding of how it develops has made it difficult to devise effective treatments. The research proposed in this application will address this problem by examining how repetitive stretch-induced remodeling of the non- cellular components of heart muscle (i.e., the cardiac extracellular matrix) leads to persistent fibrotic collagen deposition and a sustained reduction in cardiac compliance that promotes the development of HFpEF in patients with chronic coronary artery disease (CAD). Improved understanding of this process is anticipated to reveal new targets for therapies designed to prevent or reverse heart muscle stiffening in CAD patients at-risk of developing HFpEF and significantly improve the quality of life and survival of Veterans with this common condition.